Role of Microglia in Prenatal ethanol exposure-induced Impairment of Endocannabinoid Signaling

Prenatal ethanol exposure (PE) leads to fetal alcohol spectrum disorders (FASD), which consist of many
cognitive/behavioral deficits including learning disabilities, attention and executive function deficits,
increased addiction risk, and mood disorders. FASD is the most preventable neurodevelopmental disorder,
yet the prevalence is still high which is at least 2-5% in the US and the world. Therefore, developing effective
interventions is an important goal for FASD research.
Persistent synaptic dysfunctions including immature synapses are critical cellular mechanisms mediating
cognitive/behavioral deficits in FASD. Currently, the underlying mechanisms for these effects are not clear. We
have shown PE leads to microglial activation and aberrant endocannabinoid (eCB) signaling during adulthood.
Both microglia and eCB signaling play a critical role in the maturation, maintenance, and regulation of synaptic
functions in the brain. Furthermore, increased eCB release from activated microglia has been reported to
counter neuroinflammation. We have also observed that reducing microglial activation is associated with
normalized eCB signaling, synaptic functions, and behaviors in PE animals. These observations lead to our
central hypothesis that PE-induced persistent microglial activation leads to aberrant tonic eCB signaling, which
contributes to long-lasting impairments in synaptic maturation/dysfunctions and behavioral deficits. This
hypothesis will be verified using the ventral tegmental area dopaminergic (VTA DA) neurons as a model
system because these neurons represent an excellent approach for studying eCB signaling and synaptic
functions. Furthermore, persistent microglial activation, aberrant tonic eCB signaling, and impaired synaptic
maturation/dysfunctions have been observed in the VTA. The PE-induced synaptic dysfunctions of VTA DA
neurons are also associated with a clearly defined behavioral deficit - increased addiction risk. There are three
Specific Aims utilizing multidisciplinary approaches to systematically verify the central hypothesis.
Aim 1 will thoroughly characterize the dose and sex effects of PE-induced impairments in tonic eCB
signaling, synaptic maturation/homeostasis, and microglial activation. Aim 2 will test the hypothesis that PE-
induced aberrant tonic eCB signaling is caused by increased eCB synthesis/release from activated microglia.
Aim 3 will test the hypothesis that reducing microglial activation in PE animals can restore synaptic
dysfunctions and behavioral deficits.
The results of the proposed studies will lead to important understanding in the cellular mechanisms
mediating the persistent cellular and cognitive/behavioral deficits of PE. The results also fill a knowledge gap
regarding how PE impacts the neuron/microglia interaction, a new exciting area of research. Lastly, the
approach employs various methods aiming at reducing microglial activation to rescue cellular and behavioral
deficits induced by PE. Therefore, the results can be readily translated to intervention strategies for FASD.

Public health relevance
Fetal alcohol spectrum disorders (FASD) caused by prenatal alcohol exposure have high prevalence (2-5%) in the US and the world. The proposal will investigate if prenatal ethanol exposure-induced persistent microglia activation contributes to impaired endocannabinoid signaling, which in turn leads to various synaptic dysfunctions and behavioral deficits. We will also investigate if reducing microglia activation can lead to normalization of PE-induced synaptic dysfunctions and behavioral deficits.